Integrating Next Generation Simulator Training and Operating Room Performance Assessment into Orthopedic Residency Programs

Project Summary/Abstract
The long-term goal of this research is to improve patient safety by establishing simulator training and
evaluation of surgical skills as essential components of orthopedic residency programs. Many orthopaedic
surgeries involve the challenging integration of fluoroscopic image and video interpretation with skillful tool
manipulation to achieve well-defined objectives. Simulation has proved beneficial in this context for surgical
trainees, but programs have been slow to embrace this advance, and methods for evaluating operating
room (OR) performance of these skills to document improvement have been lacking. Objectively measuring
skill in the OR is a critical step toward this goal because it allows skills training to be linked to performance
in surgery. This is an important missed opportunity. The proposed research will advance objective
measurement techniques that are critically needed to speed improvement in resident performance on
technical skills, ultimately reducing costs while enhancing patient safety. The long-term goal will be
achieved by partnering with the American Board of Orthopaedic Surgery (ABOS) to more tightly integrate
surgical skills training and simulation into pre-certification policies. For this reason, researchers at the
University of Iowa are leveraging the skills and experience of existing ABOS grant-funded research groups
at the University of Rochester and the University of Texas Health in Houston to pursue this goal.
The proposed research approach is based on our multi-institution simulation studies with novel surgical
simulators and on our previous, AHRQ-funded, ground-breaking analysis techniques for assessing task-
specific, detailed, OR performance. Our central hypothesis is that orthopedic surgical skill competence can
be objectively, quantitatively, and reliably measured from behaviors observable in fluoroscopy and video
routinely collected in the OR. Our research team is well poised for this work; our core multi-disciplinary team
of engineers, surgeons, psychometricians have collaborated for nearly a decade to improve orthopedic
residency training. Our team is now partnered with the ABOS to advance simulation as a tool for training
orthopaedic residents and assessing performance prior to qualifying for certification. Aim 1 of the proposed
research is to measure differences in resident OR performance from objective analysis of surgical imagery,
and speed up these measurements. Aim 2 is to determine how differences in simulator training correlate
with skills demonstrated in the OR, and use this information to improve training programs. Aim 3 is to
identify individual differences in skills among residents, both in the skills lab and in the OR, and use this
knowledge to improve individual training. This research is innovative because it demonstrates and
disseminates new skill assessment techniques critically needed to hasten improvement in orthopedic
resident performance, ultimately reducing costs while enhancing patient safety.

Public health relevance
Project Narrative The long-term goal of this multi-institutional research is to improve patient safety by establishing simulator training and evaluation of surgical skills as essential components of orthopedic residency programs. Objectively measuring skill in the OR is a critical step toward this goal because it allows skills training to be linked to performance in surgery; skill assessment in the lab guides progress to the OR, and assessment in the OR informs skills lab methods and benchmarks. This research is innovative because it demonstrates and disseminates new skill assessment techniques critically needed to hasten improvement in resident performance, ultimately reducing costs while enhancing patient safety.